Core A: Administrative Core

Administrative Core (Core A) Abstract
The Administrative Core will provide: 1) the overall scientific/operational oversight of and 2) clinical translational
integrative activities for the UNC CF RTCC. The Administrative Core will arrange and facilitate the committees
required for CF RTCC leadership, governance, including budgets and record, and communication. In this
context, the Administrative Core will oversee designation of CF RTCC “members” and “associate members”, will
promulgate the guidelines for Core usage by the UNC CF RTCC community, will generate guidelines for sharing
of UNC CF RTCC resources, and will conduct the relevant processes should changes in directorship be
necessary. The Administrative Core will also oversee all training activities of the UNC CF RTCC. The
Administrative Core will oversee the Enrichment Program. It will arrange for experts to visit the UNC campus
and provide mechanisms for critical feed-back on the CF RTCC program. In parallel, the Administrative Core will
provide services, advice, and synergy for: 1) the tissue/specimen acquisition requirements of CF RTCC GI and
pulmonary investigators; 2) provide study guidance and biostatistical assistance to study investigators; and 3)
coordinate/guide access to key biomarkers for clinical studies. Direct services and integration with existing
CTSA, Foundation, and other P01/P30 Cores will be provided.